Generalized prediction errors in the human cerebellum

Project Summary
In addition to motor control and learning, the cerebellum is intimately linked to cognition. This project is
designed to closely examine the cerebellum's role in nonmotor domains, namely, reinforcement learning and
statistical learning. We hypothesize that the structure's core computations for sensorimotor learning can be
generalized to nonmotor contexts. It is critical to understand how the cerebellum contributes to nonmotor learning
– this knowledge will support the development of novel mechanistic and clinical insights into cerebellar function,
and human learning in general.
Foundational theoretical work has described how the cerebellum typifies an ideal substrate for supervised
motor learning. This theory made testable empirical predictions that have been borne out in experiments in
animals using tasks such as Pavlovian eyeblink conditioning and vestibular-ocular reflex adaptation, revealing
facts about cerebellar sensorimotor processes in exquisite detail. But what about a cerebellar role in other task
domains? Here we address this question. The proposed work integrates behavioral, neuroimaging, and
computational techniques to develop a new framework for generalized cerebellar learning computations.
The research plan centers on three Specific Aims. In Aim 1 we use computationally guided functional
neuroimaging (fMRI) to examine the role of the cerebellum in reinforcement learning. We test the idea that the
cerebellum processes reward predictions and prediction errors, the core computations of reinforcement learning.
We also posit a constraint on cerebellar learning computations, namely that the structure only contributes to
learning when the temporal interval between events is brief (i.e., subsecond). Aim 2 takes a similar approach to
the domain of visual statistical learning, examining sensory predictions and prediction errors in the cerebellum
and further testing the proposed timing constraint. In Aims 1-2 we also measure cerebro-cerebellar connectivity
to position the cerebellum within broader task-specific learning networks, and to ask if cerebro-cerebellar
connectivity covaries with behavior. In Aim 3 we examine causal contributions of the cerebellum to nonmotor
learning, testing a large sample of individuals with cerebellar pathology and contrasting their behavior with
matched controls. Computational analyses will be used to detect and characterize the hypothesized deficits. This
project proposes a new framework for understanding the contributions of the cerebellum to nonmotor learning
and will provide new insight into the broader role of the cerebellum in health and disease.

Public health relevance
Project Narrative The cerebellum contains more neurons and uses more energy than the rest of the brain combined, and in addition to its well-known role in motor control, this remarkable structure has been implicated in language, working memory, cognitive control, and social cognition. Prominent theories of cerebellar computation typically focus on its role in error-based motor learning. The focus of this project is to explore the idea that cerebellar contributions to learning in nonmotor domains may involve the same prediction and error-based learning principles observed in cerebellar motor learning, thus refining current models of cerebellar function in health and disease.